DP21-001 Mississippi Pregnancy Risk Assessment Monitoring System (PRAMS) - Component A

PROJECT SUMMARY/ABSTRACT
Mississippi continues to experience challenges in its healthcare delivery and the health outcomes of its
citizens—among them our state’s pregnant women and newborns. The Mississippi State Department of Health
(MSDH) proposes to continue its collaboration with the Centers for Disease Control and Prevention (CDC),
along with its individual state and territorial PRAMS programs, by participating in the CDC PRAMS Program’s
Component A: Core Surveillance initiative. Under the continued leadership of Lei Zhang, PhD, MS, MBA, the
Mississippi PRAMS Program has identified three specific aims and, within those aims, it has developed five
goals:
Aim 1: Utilizing the CDC PRAMS protocol, implement the Mississippi PRAMS Program to optimize
surveillance practices and data captured of Mississippi’s pregnant women, their outcomes, and issues they
encountered immediately prior to, during, and shortly after their pregnancy.
Goal 1: Implement population-based surveillance within Mississippi on selected maternal behaviors and
experiences that occur prior to, during, and shortly after pregnancy among women with a recent live birth,
including emerging issues and post-disaster surveillance needs, as they arise.
Goal 2: Ensure surveillance data is of high scientific quality, timely, and comparable to other jurisdictions
by following the methodology documented in the CDC PRAMS protocol.
Aim 2: Working with CDC, the Mississippi PRAMS Steering Committee and other Mississippi stakeholders,
provide analysis of Mississippi PRAMS data that is informative and supports relevant public health practices,
research, and programs.
Goal 3: Conduct comprehensive analyses of Mississippi PRAMS data based on a written analysis plan
designed to inform programmatic activities, research, and public health practice.
Goal 4: Translate and disseminate analytic results into useable information for public health action that
can guide program development and evaluation, in collaboration with the Mississippi PRAMS Steering
Committee.
Aim 3: Collaborating with public health officials, legislators, and researchers both within Mississippi and
throughout the nation, address strategies to improve health equity and health outcomes among pregnant
women and their newborn infants.
Goal 5: Advance public health efforts that focus on preventable causes of infant mortality and maternal
mortality with a health equity focus utilizing collaborative research and strategic partnerships.

Public health relevance
PROJECT NARRATIVE Mississippi continues to experience health challenges among the state’s pregnant women and newborns. The Mississippi PRAMS Program collects population-based data that monitors key risk factors, maternal behaviors, and access to care for Mississippi mothers and their infants. These data are then used to provide services that improve the health outcomes of this vulnerable population.